Regulation of intercalated cell function by the mineralocorticoid receptor

7. PROJECT SUMMARY AND RELEVANCE:
While Na+ intake exacerbates hypertension, blood pressure also rises with increased Cl- intake,
independently of Na+, making Cl- intake and renal Cl- absorption critical in blood pressure regulation.
Aldosterone administration in vivo increases NaCl uptake by the cortical collecting duct (CCD) primarily
through principal cell-mediated Na+ absorption and intercalated cell-mediated Cl- absorption, which occurs in
exchange for HCO3-, largely through the Cl-/HCO3- exchanger, pendrin. How Cl- contributes to hypertension
and, in particular, how aldosterone stimulates IC Cl-/HCO3- exchange is poorly understood.
Aldosterone’s signaling mechanism in principal cells is well established. 11 HSD2 metabolizes cellular
glucocorticoids enabling aldosterone binding to the MR (Nr3c2), thereby stimulating ENaC. However,
published and preliminary data show that the signaling mechanism(s) of aldosterone and the MR are very
different in ICs. First, 11 HSD2 is not expressed in ICs. Second, MR inhibitors reduce IC transporter
abundance even in the known absence of aldosterone. Third, published and preliminary data show
angiotensin II and a high NaCl diet can activate the MR independently of aldosterone, likely through a
mechanism involving Rac1, a GTPase in the Rho family, that regulates cytoskeletal reorganization and gene
expression. We observed that Rac1 gene ablation or Rac1 inhibition reduces pendrin abundance in
angiotensin II-treated mice. We observed that increased NaCl intake reduces Cl- absorption and Cl- transporter
abundance in CCDs from untreated mice, but increases the apical plasma membrane abundance of
intercalated cell Cl- transporters in angiotensin II-treated mice. We therefore hypothesize that IC MR activation
occurs through or independently of aldosterone. We also hypothesize that angiotensin II-induced IC MR
activation occurs through Rac1 and the MR, which act a molecular switch, by which the effect of NaCl intake IC
Cl- transporter abundance and function (IC Cl-/HCO3- exchange) changes from inhibitory to stimulatory. To
study IC transporter regulation by the IC MR, we developed mice lacking the mineralocorticoid receptor and
Rac1 in intercalated cells (IC MR KO and IC Rac1 KO mice). Determining how aldosterone and angiotensin II
target intercalated cells may provide additional targets for hypertension.
Proposal Aims are to determine: 1) if the mineralocorticoid receptor modulates intercalated cell
transporter abundance and function, blood pressure and salt balance, 2) if the mineralocorticoid receptor
stimulates intercalated cell function independently of aldosterone or aldosterone binding and 3) If angiotensin II
acts through the MR and Rac1 to modulate the effect of NaCl intake on IC transporter abundance and function.
We will examine the effect of K+, aldosterone, angiotensin II and the MR on intercalated cell transporter
abundance and function in vivo and in vitro with quantitative real time PCR, immunohistochemistry,
immunogold cytochemistry, renal tubules perfused in vitro and in whole animal studies.

Public health relevance
8. PUBLIC HEALTH RELEVANCE STATEMENT (NARRATIVE): Hypertension has grown to epidemic levels in the industrialized world and is a major risk factor for cardiovascular and renal disease. Blood pressure rises with increased salt (NaCl) intake due to increased NaCl uptake by the kidney. The purpose of this proposal is to determine how a minority cell type in kidney (the intercalated cell) regulates Cl- uptake by the kidney and thereby regulates blood pressure.